States and transitions in the initiation and maintenance of melanoma

PROJECT SUMMARY
The presence of combinations of oncogenic gene mutations is characteristic of many types of cancer. When
such mutations are genetically engineered into mice, the resulting cancers have proved to be valuable models
of human disease. Yet the fact that only a fraction of the appropriately engineered cells in such models
typically give rise to tumors suggests that additional random steps—other than mutation—are required for
tumor initiation. In mouse models of melanoma, there is growing evidence that some of those steps are non-
genetic involving, for example, stochastic switching of cell fate—a process that has been documented in
melanoma cell lines, and is thought to account for the high degree of cellular heterogeneity observed in
melanoma. Another type of stochastic, non-genetic change can occur as a result of collective processes,
whereby random fluctuations in cell number, density, or spatial organization allow populations of cells to
permanently escape growth control. Here we analyze a series of mouse melanoma models that vary in the
number of engineered mutations they contain and numbers and types of malignant and benign lesions they
produce, seeking to elucidate the non-genetic mechanisms underlying cancer initiation. We start by using
single cell transcriptomics and novel computational methods to rigorously define the cell states that are
available to melanoma cells in different genotypes, determine when they arise, infer their transition probabilities,
and examine which of these states are present in human melanoma and how they are spatially organized.
Next, we use molecular barcoding approaches to directly track cell state transitions, identify the potential
molecular regulators of these transitions, examine potential symbiotic relationships between cell states, and
examine how the innate immune system influences tumor initiation and cell state transitions. To test whether
cancer is initiated by collective escape from growth control, we will assess experimentally whether, just by
altering cellular circumstances, cells committed to become cancer can be reverted to normal, and cells
destined to behave normally can be driven to become cancer. The work described here has the potential to
change established views of melanoma initiation, identify new approaches for early detection, and lead to the
identification of new therapeutic strategies for melanoma prevention.

Public health relevance
NARRATIVE Medical research has emphasized the importance of mutations in causing melanoma, yet it is increasingly clear they are only part of the story. Evidence from studies in animal models indicates that random events of a non-genetic nature are just as important in melanoma initiation. Here we use a combination of genetically engineered mouse models, advanced bioinformatics, mathematical modeling, and advanced cellular tracking methods to identify non-genetic factors that influence the transformation of melanocytes into melanoma, in pursuit of new approaches for cancer prevention and early detection.